A quick, and robust, and unbiased platform for circular RNAs isolation, discovery and profiling.

The goal of this proposal is to develop and validate a novel platform for the enrichment of the complete repertoire
of circular RNAs (circRNAs). Thousands of circRNAs have been reported since their discovery >40 years ago
from human transcriptome. The importance of circRNAs can be gauged from the fact that they are broadly
expressed in eukaryotic cells, show cell and tissue-type specificity; and their expression is often conserved
across species. CircRNAs have been implicated in neurological diseases, innate immunity, hepatocellular
carcinoma and lung fibrosis demonstrating their role in cellular physiological and pathological pathways. The
present approaches are reported to be biased in enriching circRNAs repertoire. Given their importance in various
diseases, there is an urgent and unmet need for efficient circRNA isolation technology. In Phase-I application,
we proposed two specific aims to develop Quick-circRNA platform, validate and compare its efficacy with current
methods. In aim-1 we will develop and establish Quick-circRNA platform in various conditions and cell types in
obtaining uniform an unbiased enrichment of circRNAs. In aim-2 we will compare the efficacy of Quick-circRNA
with known methods in various cellular conditions. We believe that phase-I proposal will provide a benchmark
for phase-II, which can streamline the Quick-circRNA platform for enriching circRNAs with high reproducibility
and efficiency. In the end, we will develop a quick, and robust, and unbiased platform for circular RNAs isolation,
discovery and profiling.

Public health relevance
Project Narrative Circular RNAs are rapidly emerging as a major regulators of gene expression, which elicit influence on cellular physiology and pathology, resulting in many diseases. The proposal addresses the need for the development of an ideal platform which can enrich complete repertoire of circular RNAs. This platform will enable to identify novel circular RNA sequences with their abundance which will ultimately give us more insights about splicing, and will further, revolutionize our understanding of the complex and dynamic nature of the transcriptome.